Microneedle patch delivery of replication-inducible monkeypox vaccine

ABSTRACT
Monkeypox virus (MPXV) was declared a global health emergency of international concern with over 96,000 cases
globally in 117 countries. Various nations, including the USA, UK, and Canada, have implemented a "ring vaccination"
strategy to curb MPXV spread, a selective vaccination approach successful in containing smallpox and Ebola
outbreaks. The Centers for Disease Control and Prevention (CDC) recommends vaccination for individuals at high
risk of MPXV infection. However, there is currently no vaccine specifically developed against MPXV. Smallpox
vaccines, assumed to be 85% effective and providing cross-protective immunity, are recommended by the WHO and
CDC. Despite minimal testing against MPXV, these vaccines, including JYNNEOS (Imvanex or Imvamune) and
ACAM2000, have been applied to prevent MPXV infection. JYNNEOS, a live non-replicating virus vaccine, is
administered in two injections over four weeks, while ACAM2000, a live replication-competent virus preparation, is
given by pricking the skin surface. Both vaccines have side effects, with JYNNEOS causing mild reactions like
headache, fatigue, nausea, and injection site reactions. ACAM2000, on the other hand, presents more adverse
complications, including fever, rash, lymph node swelling, and serious concerns such as high rates of myocarditis
and pericarditis. It is considered unsafe for specific populations, such as pregnant women, infants,
immunocompromised individuals, or those living with HIV. JYNNEOS stands out for its lower reactogenicity compared
to traditional smallpox vaccines. To address existing concerns and limitations, we propose testing a novel MPXV
vaccine based on a replication-inducible ACAM2000 vaccine. Through genetic engineering, we have generated
ACAM2000 live vaccine strain Tet-On replication-inducible in the presence of tetracyclines (DOX), hypothesizing that
this modification will retain comparable immunogenicity of ACAM2000 with an enhanced safety profile. To localize
replication at the immunization site, we propose delivering the replication-inducible vaccine and DOX intracutaneously
using our microneedle array (MNA) delivery patch platform. Our aims are to a) develop a tetracycline-dependent
replication-inducible MPXV vaccine, b) compound the vaccine and tetracyclines into MNA delivery patches, c) assess
immunogenicity and safety in mouse and non-human primate models, and d) evaluate the selected vaccine in SIV
immunocompromised non-human primates.

Public health relevance
NARRATIVE In the face of a global health emergency caused by Monkeypox virus (MPXV) with over 96,000 cases across 117 countries, nations like the USA, UK, and Canada are employing a "ring vaccination" strategy reminiscent of successful containment methods for smallpox and Ebola outbreaks. Despite the absence of a dedicated MPXV vaccine, the CDC recommends smallpox vaccines like JYNNEOS and ACAM2000, assumed to be 85% effective with cross-protective immunity, with JYNNEOS offering a safer alternative due to fewer side effects. A novel proposal for an MPXV vaccine emerges: a replication-inducible ACAM2000 vaccine engineered for enhanced safety, administered via a microneedle array delivery patch, aiming to maintain immunogenicity while reducing adverse effects and revolutionizing MPXV prevention.